Novel mechanisms regulating muscle growth and regeneration: elucidating the Klotho/Jmjd3/Wnt axis

Project summary

The ability of skeletal muscle to grow and respond to injury and disease largely depends on a population of
myogenic stem cells, called satellite cells. In developing or injured muscle, satellite cells are highly-­activated
and proliferative. Some daughter cells then undergo a complex program of differentiation that is necessary to
establish or maintain muscle health and function. Perturbations of mechanisms that regulate satellite cell
proliferation or differentiation can lead to loss of normal muscle function and, in some cases, reduce lifespan.

We have discovered that the protein Klotho regulates satellite cell development in young, healthy muscle. As
we explored the mechanisms through which Klotho affects satellite cells, we learned that Klotho reduces
expression of an enzyme, Jmjd3, that activates genes by removing a silencing mark from lysine 27 on histone
3 (H3K27). In addition, the Klotho-­induced reductions in Jmjd3 are associated with increased H3K27
methylation and reduced expression of Wnt-­related genes that regulate myogenesis. Together, the
observations suggest a novel mechanism through which myogenesis is regulated, involving signaling through a
Klotho/Jmjd3/Wnt-­mediated pathway. Furthermore, the potential biological importance of the pathway is
emphasized by our findings that the targeted deletion of Jmjd3 in satellite cells produced reductions in Wnt
signaling, defects in myogenesis and death in neonatal mice.

The central hypothesis of our proposed investigation is that signaling through the Klotho/Jmjd3/Wnt pathway
plays an important role in myogenesis by regulating satellite cell numbers and differentiation. Furthermore, we
propose that this pathway is conserved throughout life, beginning with the first appearance of satellite cells at
the fetal muscle fiber surface and continuing into adulthood, when satellite cells are activated by injury or
disease. We propose to test that hypothesis through the following Specific Aims.

Aim 1. Determine the effects of modulating Klotho and Jmjd3 on post-­natal muscle growth and differentiation.
Aim 2. Determine the effects of modulating Klotho and Jmjd3 on muscle regeneration following acute injury.
Aim 3. Determine the function of satellite cell Jmjd3 in late, fetal, muscle development.

The proposed experiments will establish the importance of a novel mechanism that regulates satellite cell
development and response to muscle injury. We believe that the outcomes of this investigation will deepen our
knowledge of vital mechanisms that regulate muscle development and adaptation and will also provide new
insights into the response of muscle to injury and disease.

Public health relevance
The long- term ability of skeletal muscle to grow and respond to injury and disease largely depends on the numbers and functions of a population of myogenic stem cells, called satellite cells. In this investigation, we will establish a novel molecular mechanism that can regulate the numbers and function of satellite cells in healthy, developing muscle and in regenerating muscle following injury.